Discovery of antiviral inhibitors for the treatment of orthopoxvirus infections

PROJECT SUMMARY
Smallpox (caused by variola virus infection) was one of the most destructive diseases in human history,
resulting in 300-500 million deaths in the twentieth century alone until it was finally eradicated in 1980.
Following elimination of variola virus, global vaccination programs were eventually halted and as a result, most
of the world’s population is no longer immunologically protected from smallpox nor does it enjoy cross-
protection to other orthopoxviruses. There are two drugs approved for smallpox disease, however, both
compounds possess significant limitations. A lack of therapeutic options for treating orthopoxvirus infections
continues to expose the population to grave risk from a smallpox bioweapon as well as future zoonotic
orthopoxvirus infections. During the course of the Phase I funding period, we will execute a hit finding
campaign against a library of >200,000 compounds with optimal drug-like properties. Quality hits that emerge
from the assay will be subjected to follow-on testing that will investigate the potency, selectivity, and
mechanism of action. The most interesting of these compounds will be subjected to medicinal chemistry driven
hit-to-lead to explore structure-activity relationships (SAR). The overall goal of this project is to discover one or
more novel lead series which is defined as a chemotype inhibitor that demonstrates tractable SAR, potent
antiviral activity against variola virus and other orthopoxviruses with minimal cytotoxicity. Success in these
endeavors will trigger the submission of a Phase II application that will advance the program from Early Lead
Optimization through to Candidate Selection.

Public health relevance
PROJECT NARRATIVE In addition to safe and effective vaccines, direct-acting antivirals with complementary mechanisms of action, patterns of resistance and improved toxicity profiles are desperately needed for the Strategic National Stockpile (SNS) to adequately deter the use of smallpox as a bioweapon and to prepare for zoonotic orthopoxviruses with pandemic potential. Following the eradication of smallpox and the subsequent end of the global vaccine campaign, most of the world’s population lost immunological protection to variola virus and to infection by all other orthopoxviruses. As a result, there has been a significant increase in the number of orthopoxvirus spill over events from animal reservoirs into humans. To better prepare for both natural and deliberate threats from orthopoxviruses, we propose high throughput screening of a diversified 200,000 small- molecule library to identify novel antiviral inhibitor classes for the treatment of smallpox disease and other orthopoxviruses with pandemic potential.